GUANIDINES ON RENAL STRUCTURE ®IONAL VASCULAR DYSFUNCTION IN DIABETIC RATS

We examined the effects of aminoguanidine and methylguanidine on vascular dysfunction, glomerular structural changes, and indexes of early and late non-enzymatic glycation in 7-month streptozotocin-induced diabetic rats. Hyperglycemia in diabetes is associated with polyol formation, as demonstrated by isotope dilution mass spectrometry, in various rat tissues. Kidney weight, glomerular volume, fractional mesangial volume, glomerular capillary basement membrane width, and urinary albumin excretion were increased in diabetic rats. These discordant effects of aminoguanidine on diabetes-induced vascular changes versus parameters of nonenzymatic glycation are consistent with a multifactorial pathogenesis of diabetic complications, including roles for metabolic imbalances independent of nonenzymatic glycation. To the extent that glomerular matrix accumulation and increased regional albumin permeation in chronically diabetic rats are sequelae of nonenzymatic glycation, these find ings point to an important role for early glycation reactions and products.